Developmental Research Pilot Project

Alaska INBRE 4 – DEVELOPMENTAL RESEARCH PROJECT PROGRAM PROJECT SUMMARY
The AK INBRE 4 Developmental Research Project Program is designed to build excellence in biomedical and
behavioral research of developing faculty and investigators within our network of primarily undergraduate
institutions (UAS and UAA), Tribal health organizations (SCF and ANTHC), and the lead, doctoral institution
(UAF) by: (i) offering competitive pilot research grants to faculty to improve their research success and ability
to compete for ongoing, independent research grants; (ii) supporting science advisors and career development
opportunities for pilot grant recipients; and (iii) providing clear expectations to pilot grant recipients for meeting
goals of the project, publishing, and proposal development that will maintain their eligibility for continued
INBRE support and transition to independent researcher. Workshops on proposal development and career
planning will be offered to all network participants, but participation is a requirement for pilot grant recipients.
Training in responsible research conduct, compliance, and laboratory safety will also be required. Applications
are sought in the continuing One Health research theme of AK INBRE 4 (biomedical health of and interactions
among humans, animals and the environment), however other basic or clinical and translational research
proposals are invited and reviewed. The AK INBRE Principal Investigator (PI/PD), Brian Barnes, will continue
to lead the Developmental Research Project Program (DRPP) and oversee the appointment of science
advisors in partnership with the AK INBRE Program Coordinator (PC), Cheryl Wilga, and agreement by the
External Advisory Committee (EAC) Chair, Glen Gaulton (AK INBRE 4 Overall Specific Aim 1). Candidate
investigators are encouraged to discuss their ideas for pilot proposals with the PI, PC, and co-I, Jane Shelby,
ahead of time, and applications received two days before the deadline will be reviewed administratively for
completeness by staff who work with applicants to achieve on-time and compliant submissions. Applicants
must include a letter from their dean or supervisor stating that, if funded, they will have at least 6 of 12 months
available to conduct research and for professional development and training students over the budgeted
period. Pilot research applications will be evaluated by external experts in the field and discussed and ranked
by the EAC during on site annual meetings, with input from the PI, co-I, and PC. Recommended applications
will be conveyed to the NIGMS for administrative approval. AK INBRE 4 DRPP awards are for 12 months with
up to $75,000 in direct costs per year for one investigator and up to $100,000 for direct costs per year for
multiple investigators as an incentive for collaborative work within the network on multidisciplinary projects.
Funded PIs can compete for continuation funding for a second year.